Effect of shear stress on coronary smooth muscle maturation

Project Summary
The broad objective of this proposal is to understand why the developing coronary arteries are consistently
formed at specific locations. During development of the coronary arteries, numerous immature coronary
strands connect to the aorta and then remodel to form the two mature arteries observed in the adult heart.
During this remodeling process, one of the biggest changes applied to the newly connected coronary
vasculature is the sudden onset of fluid shear stress, yet the regulatory role of fluid shear stress on the
development of the coronary vasculature is completely unknown. This proposal specifically addresses how the
onset of blood flow, which causes shear stress, induces signaling pathways that would promote smooth muscle
migration, proliferation, and maturation. Aim 1 examines the environment surrounding the aorta during the
early stages of smooth muscle recruitment to the coronaries. Low levels of shear stress are predicted to
promote expression of ET1 and thus lead to matrix metalloprotease (MMP) activity, yielding an environment
that promotes smooth muscle migration. This aim will evaluate ET1, MMP2, and MMP9 expression as well as
smooth muscle proliferation in the developing coronary arteries of the chick embryo. In ovo injection of MMP2
and 9 inhibitors will confirm the necessity of these MMPs for smooth muscle migration. Aim 2 examines the
effects of increased levels of shear stress on cell signaling, particularly the transcription factor KLF2 and the
nitric oxide synthase eNOS. High levels of shear stress are predicted to induce KLF2 and lead to eNOS
phosphorylation, which promote smooth muscle maturation. Asymmetrical shear stress would thus selectively
mature smooth muscle, explaining the consistent patterning of the coronary arteries. In ovo inhibition of eNOS
activity will confirm whether eNOS activity is required for smooth muscle maturation and coronary artery
stability. Most of the proposed techniques are easily accessible to undergraduate research students, and the
preliminary data were generated by undergraduate students, supporting the feasibility of this project at the
University of Portland. Altogether, this proposal sits at the intersection among physical forces, molecular
responses, and cellular behavior, with the end objective of understanding the formation of the coronary
arteries. By better understanding the normal development of these arteries, the proposed research will support
future work to examine how these developmental processes go awry, leading to life-threatening congenital
coronary artery anomalies.

Public health relevance
Project narrative The coronary arteries supply the heart with blood and are critical for life, yet many questions remain about how they form during fetal development. This research proposal focuses on what happens when blood begins flowing through the developing coronary arteries, with the specific goal of determining why some coronary arteries are strengthened with supportive muscle. This knowledge will help scientists and physicians better understand who is likely to have abnormal coronary arteries and may benefit from careful monitoring, potentially lengthening and/or saving lives.